Mass Spectrometry and Proteomics

PROJECT SUMMARY: MASS SPECTROMETRY & PROTEOMICS MODULE
The Vanderbilt Vision Research Center (VVRC) includes investigators with a strong interest in
discerning how protein signatures govern functional circuits in the visual pathways and predispose patients
towards disease and response to treatment. These relationships require the ability to measure protein content
and patterns in large numbers of samples, transgenic animals, and even within highly localized intact tissues.
The purpose of the VVRC Mass Spectrometry & Proteomics Module is to provide a comprehensive
resource for all mass spectrometry needs for investigators needing proteomics, metabolomics, or tissue
imaging via mass spectrometry. This module provides access to state-of-the-art mass spectrometry,
proteomics, and mass spectrometry tissue imaging facilities via subsidized scholarship use of the Vanderbilt
Mass Spectrometry Research Center (MSRC). The MSRC comprises the Mass Spectrometry Core
Laboratory, the Proteomics Laboratory, and the Tissue Imaging Core, all with bioinformatic support through the
MSRC Bioinformatics Group. VVRC support translates on a dollar-for-dollar basis to scholarships issued to
VVRC investigators applicable for all MSRC services. This scholarship system is implemented by the VUMC
Office of Research and is utilized instead of a discount or co-pay via the VUMC ILab accounting system. In the
current funding cycle, the Proteomics Service Module was used by 12 investigators who authored 142
publications using the service, including 6 current NEI R01 holders. In the next cycle, we expect moderate to
extensive use by 22 of 52 VVRC faculty members, including 9 of 16 current NEI R01 grant holders. The Mass
Spectrometry & Proteomics Module, housed in a centralized location conveniently accessed from all parts of
campus, is directed by Professor Kevin Schey, PhD, who also directs a subset of the MSRC housed cores.
Using resources and personnel supported in part by this core grant, the VVRC Mass Spectrometry &
Proteomics Module will assist in (1) experimental design for proteomics, metabolomics, or imaging mass
spectrometry projects and (2) preparation of visual system tissues for mass spectrometry analysis and provide
(3) comprehensive proteomics service, (4) a range of small molecule and metabolomics services, (5) access
to imaging mass spectrometry (IMS) services, and (6) training to members of the vision research community in
LC-MS or IMS techniques. These services and resources will enhance the scope of experimentation NEI-
funded VVRC investigators conduct, expand the training of students and fellows involved in vision science, and
promote collaboration by providing sophisticated, high-resolution and high-throughput proteomics and
bioinformatic services to those who otherwise would not have such capabilities, including early-career vision
scientists and clinician-scientists competing for extramural funding for their laboratories.